Community Outreach and Engagement

COMMUNITY OUTREACH AND ENGAGEMENT ABSTRACT
San Diego County (SDC), the Moores Cancer Center (MCC) catchment area, is a minority-majority region, in
which non-Hispanic whites (NHWs) are not the majority population (46%). Hispanics comprise 33.5% of the
population and Asian Pacific Islanders (APIs) make up 12.8%. A sizeable percentage of individuals in SDC are
foreign-born (23.5%) and have limited English proficiency (15%). Through MCC’s Community Outreach and
Engagement (COE), knowledge of cancer burden and community needs shape its research agenda and
outreach activities to address the cancer-relevant needs of the catchment area. The overarching goal of the
MCC COE is to decrease the burden of cancer in SDC by facilitating research relevant to this burden, engaging
with communities and health care providers, and partnering with local and state agencies to disseminate and
facilitate the implementation of evidence-based recommendations. This goal is accomplished through the
following Specific Aims: 1) Assess cancer burden and use this knowledge to facilitate transdisciplinary research
relevant to the MCC’s catchment area; 2) Address cancer disparities along the cancer continuum, from primary
prevention to survivorship, through research and community engagement; 3) Disseminate evidence-based
practices and resources for cancer prevention, screening, treatment and outcomes to communities and providers
in the catchment area; and 4) Engage with regional, national, and global partners to extend MCC’s reach beyond
the catchment area and impact policy. The goal and aims of the COE are accomplished working under a structure
that includes a Steering Committee and a Community Advisory Board. MCC’s community outreach has had
substantial impact in facilitating research and policy for cancers that are prevalent in SDC and those that
disproportionately affect racial/ethnic minority and underserved populations. Future directions will build upon
ongoing activities and recently-funded research. MCC will continue to expand community-academic
partnerships, including those with federally qualified health centers, to better address the needs of medically
underserved communities. Continued efforts to enhance minority accrual to therapeutic trials and participation
in research projects are an essential part of the COE.